Novel Mechanisms and Therapeutic Targets for Pulmonary Hypertension in End-Stage Renal Disease (K23)

PROJECT SUMMARY
Cardiovascular disease is the leading cause of death for persons with chronic kidney disease (CKD) and end-
stage renal disease (ESRD). Pulmonary hypertension (PH) is an underappreciated cardiovascular complication
of kidney disease that affects up to 60% with ESRD, in whom PH increases the risk of mortality 3-fold. Despite its
high prevalence and morbidity in ESRD, the pathophysiology of PH remains poorly understood. The current
pathophysiologic paradigm emphasizes volume overload as the main cause of PH in ESRD, but volume removal
through dialysis resolves PH in only a fraction of cases. Dr. Edmonston’s long-term goal is to identify novel
pathophysiologic targets for PH in ESRD through rigorous prospective studies and investigate new therapies
tailored to these targets through efficient clinical trials. Based on published preliminary data in 4772 patients with
CKD-ESRD, >60% of PH cases had elevated pulmonary vascular resistance on right heart catheterization. This
increased pulmonary vascular resistance implicates mechanisms beyond volume overload which promote
pulmonary vasoconstriction and remodeling. The central hypothesis of this proposal is that volume-independent
changes in vascular biology caused by reduced kidney function and exacerbated by hemodialysis contribute to
PH in ESRD. Increased circulating levels of the vasoactive factors asymmetrical dimethylarginine (ADMA) and
serotonin, which cause pulmonary vascular remodeling and vasoconstriction, may serve as pathogenic links
between reduced kidney function and PH. Hemodialysis further introduces putative risk factors for PH:
subclinical hemolysis caused by hemodialysis releases free hemoglobin (Hb) into circulation that scavenges
nitric oxide (NO); and recurrent intradialytic hypoxemia promotes PH through frequent episodes of hypoxia-
induced vasoconstriction. In a prospective study, this proposal will investigate the association of each of these
volume-independent factors with PH in 150 patients with ESRD receiving maintenance hemodialysis: Aim 1 will
investigate ADMA and serotonin as mechanisms of PH in ESRD; Aim 2 will establish subclinical hemolysis and
impaired hemoglobin scavenge as hemodialysis-associated mechanisms of PH in ESRD; Aim 3 will quantify the
extent of intra- and extradialytic hypoxemia and define its association with PH in ESRD. Supported by new
preliminary data for this resubmission, PH will be estimated by tricuspid regurgitant velocity (TRV) on
echocardiogram. A longitudinal subcohort of 50 patients found to have PH on initial assessment will determine
how changes in these risk factors associate with PH progression after 6 months (Aims 1-3). To discern the
contribution of hemodialysis above the influence of ESRD, this proposal will also enroll 10 patients with ESRD
undergoing peritoneal dialysis (Aims 1-3). Execution of these scientific aims and completion of the career
development activities of this proposal, along with experienced mentorship and strong institutional support, will
position Dr. Edmonston to serve as the Principal Investigator on future R01 grants to support interventional trials
that target PH in ESRD and prospective studies which identify risk factors for PH in earlier stages of CKD.

Public health relevance
PROJECT NARRATIVE Pulmonary hypertension is a common cardiovascular complication of end-stage renal disease (kidney failure) which increases the risk of death. This proposal will identify new targets to treat and prevent pulmonary hypertension in these patients. Targets identified by this research will directly lead to clinical trials of new therapies and approaches to improve outcomes for patients with pulmonary hypertension and kidney failure.